Modifying the extracellular matrix to prevent dry eye disease and age-related Meibomian gland dysfunction (ARMGD)

Project summary
The prevalence of dry eye disease (DED) ranges from ~5 to 50% of the general population with an
estimated US$ 3.8 billion dollars in associated medical costs. Symptoms of DED include pain, fatigued
and/or sore eyes, photophobia and blurred vision, which lead to a decrease in productivity and reduce the
quality of life. Unfortunately, treatment options for DED are limited. Clinical studies suggest 85% of overall
DED cases are caused by Meibomian gland dysfunction (MGD). As humans and mice age, their Meibomian
glands (MGs) undergo age-related changes, including decreased acinar basal cell proliferation and atrophy,
and these changes result in age related-MGD (ARMGD). The precise cause of ARMGD remains elusive,
which makes the development of therapies extremely challenging.
Hyaluronan (HA) is a major extracellular component that interacts and binds to a myriad of
molecules forming complex macromolecules which regulate major physiological functions, such as
development and stem cell specification. Our recently published work shows that compound HA synthase
(Has)-1 and -3 null mice, namely Has1-/-;Has3-/- mice, have enlarged MGs when compared to age matched
wild-type (wt) mice. Our preliminary data show that the MGs of Has1-/-;Has3-/- mice continue to increase in
size throughout life, and, interestingly, these mice do not develop ARMGD. At 1 year of age, Has1-/-;Has3-/-
mice have a striking 4-fold increase in MG volume and an overall 10-fold increase in lipid production,
compared to age matched wt mice. We hypothesize that the increase in HA expression in and around the
MGs of Has1-/-;Has3-/- mice is capable of maintaining viable progenitor cells as they age, which in turn
prevents ARMGD. Specific aim 1 of this proposal will characterize the extracellular matrix in the MGs of wt
and Has1-/-;Has3-/- mice with a focus on the composition of the HA matrix. Specific aim 2 of this proposal
will analyze the distribution of MG progenitor and proliferating cells in order to identify how the MGs of Has1-
/-;Has3-/- mice enlarge over time. This aim will also characterize the lipid composition of the meibum, and
verify whether enlarged glands can prevent DED. Importantly, although Has1-/-;Has3-/- mice lack two
isoforms of the enzyme responsible for HA biosynthesis, they up-regulate the third isoform (Has2), and, in
turn, present a significant increase in HA expression in and around MGs when compared to wt mice.
Therefore, we also hypothesize that increasing Has2 expression and HA bioavailability within MGs could
prevent ARMGD in aged wt mice. Specific aim 3 will test whether Has2 overexpression and FDA approved
HA-based treatment regimens to increase the bioavailability of HA within tarsal plates and MGs can prevent
ARMGD in wt mice.

Public health relevance
Project Narrative Age related-Meibomian gland dysfunction (ARMGD) is a common eyelid disorder with a prevalence of up to 50% in the US population. Our recently published work and preliminary data show that the overexpression of hyaluronan in Meibomian glands leads to enlarged Meibomian glands and resistance to the development of ARMGD, with a striking 4-fold increase in Meibomian gland volume and an overall 10-fold increase in lipid production at 1 year of age, when compared to age-matched controls. This proposal will characterize the precise composition of the hyaluronan matrix present in Meibomian glands (Specific Aim 1), characterize how this matrix regulates Meibomian gland progenitor cells and prevents ARMGD and dry eye disease (DED) (Specific Aim 2), and allow us to develop novel strategies for treating Meibomian gland dysfunction, ARMGD and DED (Specific Aim 3).